A novel thermogel for topical treatment of ulcerative colitis with microbialmetabolite mimicry.

PROJECT SUMMARY
About one million people in the U.S. are affected by ulcerative colitis (UC), a chronic inflammatory disease that
significantly affects health-related quality of life and can ultimately lead to colorectal cancer. The disease is
variable across patients for severity (mild, moderate, or severe), extent (proctitis, distal UC, and pancolitis), and
course (relapsing-remitting or chronically active). Medical management of UC is focused on reducing
inflammation and achieving mucosal healing by first inducing and then maintaining remission. Moderate-to-
severe UC is currently treated during flares and for short courses with corticosteroids (frequently, prednisone or
budesonide), and for more sustained treatment with anti-TNF-α agents, anti-integrins, anti-IL-12/IL-23, and small
molecules, which have risks of severe adverse effects and often result in non-response. Alternative dosage
forms, such as topical formulations, are preferable to systemic therapies because they target the actual site of
disease, achieving higher concentrations in the colonic mucosa with lower systemic exposure and fewer side
effects. However, current topical approaches still suffer several limitations. Suppositories are only active in the
rectum, and foams can only reach the sigmoid colon. Current enemas are able to reach as proximal as the
splenic flexure but are not well-tolerated by patients due to retention issues, urgency, and the need for prolonged
use. Intact Therapeutics is developing a novel topical therapeutic product (INT-102) for the treatment of
moderate-to-severe, distal UC. INT-102 offers the unique combination of 1) a novel microbial metabolite-
derived agonist of the Pregnane X Receptor (PXR), which has been demonstrated to regulate the inflammatory
response, and 2) an innovative proprietary thermosensitive delivery platform (TDP) designed to achieve superior
drug delivery to the distal colon. The proposed formulation will be used to treat inflammation refractory to first-
line treatments while eschewing the side effects of current systemic therapies and overcoming the limitations
hindering the use of current topical therapeutics for moderate-to-severe UC. This SBIR Phase I project proposes
to develop the formulation with the lowest effective concentration of this new active drug (Aim 1), assess its
pharmacokinetics in vivo (Aim 2), and demonstrate its safety and efficacy profile in a murine UC model (Aim 3).
This work will be preparatory of a Phase II project in which Intact will evaluate the pharmacodynamics of the new
formulation, validate efficacy in additional colitis models and UC patient explant culture (testing the drug efficacy
related to inhibiting the target pathway), and conduct a comprehensive toxicology assessment in GLP IND-
enabling studies. By offering a new effective treatment for moderate-to-severe UC, Intact Therapeutics will
improve the health and quality of life of UC patients.

Public health relevance
PROJECT NARRATIVE Ulcerative colitis is a chronic condition that severely impacts the quality of life, has no medical cure, and is increasing in prevalence particularly in adolescence and early adulthood. Current treatments for moderate-to- severe ulcerative colitis carry the risk of severe adverse effects, increasing the risk of comorbidities for patients. Intact Therapeutics is developing a new thermogel loaded with a microbial mimicry-derived metabolite that promises to offer a new topical treatment for ulcerative colitis with an increased efficacy, excellent safety, and better patient acceptance.